The role of IL-17 signaling in alcohol-induced HCC

ABSTRACT:
Hepatocellular carcinoma (HCC) is caused by hepatitis virus HBV/HCV, non-alcoholic steatohepatitis (NASH),
and alcoholic liver disease (ALD), which typically progress from liver fibrosis, to cirrhosis and cancer. Our
preliminary data demonstrate that genetic deletion of IL-17 signaling in steatotic hepatocytes significantly
attenuates the development of HCC in ALD-injured mice, suggesting that IL-17 signaling is a target for anti-
HCC therapy. Our central hypothesis is that IL-17 signaling regulates chemokine production, de novo
lipogenesis, and TNFRI expression/turnover in steatotic hepatocytes. IL-17 signaling promotes ALD- and
NASH-induced HCC via activation of TNF/TNFRI-SREBP1/2-DHCR7-cholesterol synthesis, and suppression
of ARTS-1/NUC2-dependent TNFRI exocytosis. The goal of the study is to characterize the mechanism by
which IL-17A/IL-17RA signaling regulates responses in metabolically injured hepatocytes, and to compare the
pathways of IL-17 signaling in the experimental models of ALD- and NASH. Strategy: Responses to IL-17
signaling will be compared side-by side in ALD- and NASH-injured WT and hepatocyte-specific IL-17RA
knockout mice with HCC. We determine if IL-17 signaling is similarly activated in NASH- and ALD-injured
hepatocytes. We determine if blocking of IL-17 signaling in steatotic hepatocytes is sufficient to suppress HCC
in the metabolically injured liver. Specifically, the role of IL-17 in the pathogenesis of DEN- or (Mup-uPA)-
induced HCC in ALD- and NASH-injury will be studied in WT and hepatocyte-specific IL-17RA knockout mice
(IL-17RAΔHep mice). Development of HCC, inflammation, steatosis and liver fibrosis will be across all groups of
mice. Mutagenesis of WT and IL-17RA-deficient AFP+YAP+ HCC, and responses of steatotic hepatocytes to
IL-17A will be characterized. Specifically, we determine if chemokine secretion, cholesterol synthesis are
suppressed in metabolically injured IL-17RA-deficient hepatocytes (AIM1). We will test a novel hypothesis by
which IL-17 signaling facilitates TNF/TNFRI-Caspase2-SP1-SREBP1/2-DHCR7-dependent cholesterol
synthesis in steatotic hepatocytes via blocking ARTS-1-NUCB2-regulated TNFRI exocytosis (and possibly IL-
6, IL-1RII) thereby prolonging TNF (IL-6, IL-1) signaling and promoting alcohol-induced HCC (AIM2). Our
findings will be translated into humans by characterization of IL-17RA-TNFRI-signaling pathways in archived
human livers from HCC patients with ALD. We will test if therapeutic blocking of the key IL-17 signaling
molecules (IL-17RA, TNFRI, ARTS-1, and DHCR7) specifically in hepatocytes using N-acetylgalactosamine
(GalNAc)-conjugated antisense RNA oligonucleotides (ASOs) can effectively suppress steatosis, fibrosis, and
HCC in WT mice with NASH and ALD (AIM3). If proven, hepatocyte-specific blocking of IL-17 signaling using
GalNAc-ASOs can provide a new strategy for HCC treatment in ALD and NASH patients.

Public health relevance
HCC is a highly aggressive cancer whose incidence is on the rise, made of cells resembling hepatocytes, resulting from chronic Hepatitis B/C Virus infection, non-alcoholic steatohepatitis (NASH), and Alcoholic Liver Disease (ALD). Based on our preliminary data in experimental models, metabolic injury accelerates progression of HCC by upregulation of interleukin 17A (IL-17A). Current study will investigate the role of IL-17 signaling in the pathogenesis of ALD-and NASH-induced HCC using mouse models and patient material, and will provide new insights into therapeutic targeting of IL-17 signaling for treatment of HCC patients with ALD and NASH.